Identification and Characterization of Microbial Metabolites in Immunity

PROJECT SUMMARY
The human microbiome is a key regulator of host immune function, and growing consensus suggests this
relationship is likely mediated by host interactions with microbial derived small molecules (i.e., metabolites).
Accordingly, microbial derived metabolites have been associated with numerous autoimmune, allergic, and
infectious diseases. However, the host-microbiome circuits that form the molecular basis of these associations
have not been fully characterized, and many microbial derived metabolites have not even been formally
identified. In this proposal, we describe a strategy to identify and functionally characterize microbial derived
metabolites isolated from patients in health and autoimmunity. Our collaborative team will isolate and
characterize novel metabolites from the human microbiome, map these associations to human immune
pathways, and identify the specific host receptors that engage microbial derived metabolites. This proposal will
establish causal relationships between microbial metabolites and human immune system function.

Public health relevance
PROJECT NARRATIVE The human microbiome is known to regulate host immune system function, but the mechanisms underlying this relationship are incompletely understood. This proposal will identify causal associations between microbial derived metabolites and human immune system function in health, autoimmunity, allergy, and infectious disease. Uncovering these host-microbiome circuits may inform the development of therapeutics to treat immune-mediated disease.